National Swine Resource and Research Center (NSRRC) Years 21-25

Project Summary
The overall goal of this application is to continue and expand operation of the National Swine
Resource and Research Center (NSRRC). The NSRRC is halfway through its 19th year of
operation, and it has successfully developed the infrastructure needed to assist swine-based
research across multiple disciplines. The NSRRC has developed new models of human disease
by genetic engineering, it has recruited models created by others, and it has distributed
expertise, cells, tissues, organs, and pigs to investigators throughout the United States and
Europe. Since genetic engineering of pigs requires specialized facilities and expertise, the
NSRRC provides invaluable services to the research community by creating new genetically
engineered swine models. The NSRRC also provides training and education by interacting with
individuals, publishing manuscripts and sponsoring workshops and meetings that promote the
use of pigs for studying human diseases. The NSRRC has a state-of-the-art building with high
biosecurity, to house animals free of specific pathogens. The Specific Aims for the upcoming
grant period are as follows:
1. To operate the National Swine Research and Resource Center. Functions of the NSRRC will
continue to include: a) importation of existing swine models of human health and disease, b)
rederivation of pigs to eliminate specific pathogens, and health monitoring to assure
maintenance of a specific pathogen-free status, c) cryopreservation and storage of gametes,
embryos and somatic cells to prevent future loss of valuable models, d) distribution of expertise,
reagents, cells, tissues, organs and pathogen-free pigs, and e) creation of new genetically-
engineered pigs needed by the biomedical research community. Rigorous quality control will
ensure that only high-quality genetics are distributed.
2. To perform innovative research that will benefit the NSRRC and the biomedical research
community. Applied research projects are aimed at improving: a) the cryopreservation of pig
reproductive cells and tissues, and b) the development of improved methods for the production
of genetically-engineered pigs. The NSRRC will also serve as a site for training and educational
activities related to research employing swine models.

Public health relevance
Relevance to Public Health Pigs are the model of choice for many human diseases, and as such, they play an important role in understanding of human disease and the development of drugs and therapeutics. The National Swine Resource and Research Centers (NSRRC) provides a unique one-stop-shop for creating, curating and distributing these valuable genetics. The NSRRC supports biomedical researchers by providing animals, or assisting with innovative research to ensure reproducibility of their results.